SPATIAL PATTERN OF THE EGG CHAMBER IN DROSOPHILA

The aim of this project is the analysis how spatial asymmetries arise in the developing egg chamber of Drosophila melanogaster. We have shown that a signalling process between the germline and the overlying follicle cells establishes the dorso-ventral pattern of both the egg shell and the embryo. We found that torpedo, a central gene in this cell communication pathway, encodes the Drosophila homolog of the vertebrate Epidermal Growth Factor receptor (EGFr). We will analyze at the molecular level a set of 32 torpedo alleles which differentially affect receptor function in different cell types. To analyze the upstream germline processes involved in torpedo activation we propose a detailed genetic and molecular analysis of the gene cornichon which is presently our best candidate for encoding a ligand of the receptor. We will subsequently analyze the interactions between cornichon and gurken, fs(1)K10, capuccino, and spire, genes that also act in the germline and are involved in ligand production. This will allow us to describe the pathway of temporal and spatial control used by the system for ligand production. We will analyze the two cellular response pathways that are activated by the torpedo receptor: the establishment of dorsal follicle cell fates and the regulation of a new, ventralizing signal which is produced in the follicle cells and transmitted back to the embryo. We have identified a candidate class of genes for the first response pathway. We propose to analyze this class and identify genes that promote the establishment of dorsal follicle cell fates. We have also identified a gene (windbeutel) that acts in the second pathway and participates in the production of a new signal in the follicle cells which ultimately established embryonic cell fates. Genetic and molecular techniques will be used to analyze windbeutel. In addition, a search for additional genes that act in the torpedo pathway will be performed by screening for enhancer or suppressor mutations. We will also analyze mutations that affect early events in egg chamber patterning. This will provide information about the primary mechanisms that are used in Drosophila to establish the initial anterior-posterior and dorso-ventral asymmetries. The proposed research will allow us to determine how a spatially and temporally controlled activation of the torpedo receptor tyrosine kinase is achieved in development, and provide a detailed understanding of the different developmental pathways that are controlled by receptor activation. Excellent biochemical data on the mode of action of such receptors has been obtained using vertebrate tissue culture systems. Our studies in the egg chamber of Drosophila will complement such analyses, and yield insights into the role of such receptors in the developing organism.